Research Project 4: PFAS Mineralization in Wastewater, Recycled Water, and Water Treatment Residuals

PROJECT SUMMARY
Research Project 4 (RP4) of the Southern California Superfund Research and Training Program for PFAS
Assessment, Remediation and Prevention Center (ShARP) aims to develop practical technologies for destroying
PFAS contaminants in water, in the context of wastewater reuse and groundwater recharge into aquifers
contaminated by PFAS and other contaminants of Superfund relevance. Existing water treatment technologies
(e.g., reverse-osmosis (RO), granular activated carbon (GAC), ion exchange) can remove PFAS from water
effectively, but each of them relies on phase transfer or concentration, moving the waste stream from one
environmental reservoir to another, rather than resolving PFAS contamination permanently. These treatment
residuals may lead to downstream environmental contamination during disposal (e.g., discharge of RO brines
into surface waters or thermal incineration of spent GAC, producing volatile PFAS combustion products which
can enter the atmosphere). RP4 will develop practical means of removing PFAS from water in a manner that
leads to their destruction, to avoid environmental PFAS contamination by treatment residuals. RP4 addresses
SRP Mandate 4 to develop basic biological, chemical, and physical methods to reduce the amount and toxicity
of hazardous substances through three specific aims. RP4 aims span biological, chemical, and thermal means
for PFAS defluorination, all within the context of water reuse and groundwater recharge into PFAS-contaminated
aquifers: Specific Aim (1): Bioremediation of PFAS in wastewater by treatment with anaerobic membrane
bioreactors; Specific Aim (2): Advancing technology for chemical defluorination of PFAS in potable water,
wastewater and water reuse brines; and Specific Aim (3): Improving PFAS degradation during thermal GAC
regeneration, and monitoring of PFAS combustion products by gas phase mass spectrometry. The aims and
outcomes of RP4 complement the efforts of all research projects and all cores in the Center. Data from RP4
will be transmitted to RP2 and RP3 to inform estimates of PFAS-associated human health risk under different
scenarios. Any partially defluorinated transformation products identified by RP4 will be conveyed to RP1 and
RP3 for toxicological evaluation and fate and transport property assessment. Any unique PFAS identified by
non-target high resolution mass spectrometry in human serum samples collected by RP2 and environmental
samples collected by RP3 will be evaluated for treatability by UV/ARP and incineration in RP4. Ultimately, the
novel bioremediation, chemical and thermal defluorination advanced techniques developed in this project are
expected to provide a sustainable and effective way to reduce PFAS exposure to drinking water contamination
in the target communities and communities near Superfund and other hazardous sites.

Public health relevance
RESEARCH PROJECT 4 (RP4): PROJECT NARRATIVE Research Project 4 intends to develop three novel parallel approaches for PFAS mineralization in water, wastewater, and waste products from water treatment: microbial defluorination, chemical defluorination, and thermal defluorination. Current technologies available for PFAS remediation generally only move PFAS from one phase to another, potentially creating downstream environmental problems when concentrated PFAS waste streams are disposed. RP4 will result in the development of new methods for PFAS destruction during water treatment, so that PFAS contamination can be permanently halted rather than contaminating downstream environments.